High-throughput sequencing of synaptic partnerships and gene expression at single-cell resolution in vivo

PROJECT SUMMARY
Brain function depends on forming and maintaining synaptic connections between neurons of specific types,
yet systematic descriptions of cell-type connectivity and the molecules that instruct these relationships remain
challenging because we lack some necessary tools. Traditional approaches for measuring synaptic
connections and networks – such as whole-cell electrophysiology and anatomical reconstructions – sample
only a few cells or small tissue volumes, do not readily scale to many animals or genotypes, and do not
ascertain the molecular type and state of each cell. To bridge this gap, I have developed a barcoded rabies
virus-based method called SBARRO which stores synaptic partnership data in each cells' RNA, allowing
synaptic networks and gene expression to be measured simultaneously in hundreds of thousands of cells
using high-throughput single-cell RNA sequencing. SBARRO experiments in vitro have demonstrated that
quantitative models of cell type-specific connectivity can be systematically generated and used to discover
gene expression signatures associated with connectivity properties. Yet technical limitations related to cell
sampling, recombinant adeno-associated “helper” viruses (rAAVs) and rabies virus biology have precluded
analyses of intact brain tissue.
Here, I propose to address these limitations and advance SBARRO to generate quantitative models of synaptic
networks in vivo based on the following aims: 1) create an anatomically-informed version of SBARRO based
on spatially-resolved single-cell RNA sequencing (called “Slide-SBARRO”); 2) develop a new class of CRE
recombinase-sensitive rAAVs which deliver transgenes while reporting the recombination state of expressed
RNA; and 3) evaluate the synapse-selectivity of rabies virus transmission from postsynaptic to presynaptic
cells. I will focus on mouse striatum because: 1) striatal cell populations are now well-characterized by me and
others; 2) little is known about the synaptic organization of intrinsic striatal cell types and 3) extensive mouse
genetic tools enable Slide-SBARRO connectivity models to be carefully tested through cell-type-specific
anatomy and electrophysiology.

Public health relevance
PROJECT NARRATIVE The mammalian brain consists of hundreds of cell types which are wired up into synaptic networks in ways that are largely unknown because we lack tools to measure synaptic partnerships in a fast, easy and comprehensive way. To address this need, we developed a virus-based genomics technology in which synaptic partnership and molecular makeup information are ascertained simultaneously in thousands of individual cells, enabling sequencing-based reconstructions of cell-type-specific connectivity at scale. Here we propose to advance this technology for the analysis of intact brain tissue by using spatially-resolved sequencing to map local synaptic wiring in the mouse striatum.